Irvine Summer Institute in Biostatistics and Data Science

Irvine Summer Institute in Biostatistics and Undergraduate Data Science
Project Summary
The goal of this project is to establish a Summer Institute in Biostatistics and Undergraduate Data Sci-
ence at the University of California, Irvine. The investigators will develop short courses in modern method-
ology and practice of biostatistics and data science. These courses will highlight applications in cutting
edge biomedical research, will train students in fundamentals of biostatistics, data science, and com-
puting, and will culminate in a team project co-supervised by statisticians and biomedical scientists. In
addition, the institute will include sessions helping students improve their transferrable skills: e.g., oral
and written presentation skills. Particular attention will be paid to mentoring and career guidance. The
institute will culminate with a mini-symposium with keynote lectures and a student poster session. One
of the main goals of the proposed institute will be attracting mathematically inclined undergraduate
students, especially from groups that are underrepresented in STEM ﬁelds, to the ﬁeld of Biostatistics
and Biomedical Data Science.
UC Irvine is ideally suited for hosting the proposed institute. The institute leadership team consists
of UC Irvine Statistics faculty. The Department of Statistics at UC Irvine is heavily invested in biomedical
research directly relevant to the mission of the National Heart, Lung, and Blood Institute and National Insti-
tute of Allergy and Infectious Diseases, which guarantees that there will be no shortage of highly qualiﬁed
summer institute instructors. Design and analysis of clinical trials, causal inference, modeling of infectious
disease dynamics, analysis of big data in genomics, transcriptomics, and image analysis provide a small
sample of potential applications that will be used as examples in the institute short courses. Another ad-
vantage of Statistics faculty being at the helm of the summer institute is vast experience of the leadership
team and the rest of the department faculty in teaching and mentoring undergraduate students. The School
of Information and Computer Science, which houses Computer Science, Informatics, and Statistics Depart-
ments, is a national leader in Data Science education and research — the school is home to one of the ﬁrst
in the nation Data Science undergraduate degree programs and Data Science Institute that serves as a hub
of data-driven research at UC Irvine. UC Irvine successful recruitment of underrepresented populations
has been recognized by Hispanic-serving institution and Asian American and Native American Paciﬁc Is-
lander Serving Institution designations. The summer institute recruitment of participants will tap into UC
Irvine existing programs and infrastructure for reaching out to underrepresented student groups. The con-
ﬂuence of Biostatistics and Biomedical Data Science expertise, investment in Data Science research and
pedagogical innovations, and strong commitment to diversity and inclusion ensures that Irvine Summer
Institute in Biostatistics and Undergraduate Data Science will be a successful endeavor.
1

Public health relevance
Project Narrative This project aims to establish a Summer Institute in Biostatistics and Data Science at the University of Cal- ifornia, Irvine. The institute will attract new students to the ﬁelds of Biostatistics and Biomedical Data Science. Students will be trained in methodology and computing and will apply this training to a data analysis project under guidance of biostatistics and biomedical science co-mentors. The investigators will make a concerted effort to recruit students from groups underrepresented in the biomedical and mathe- matical sciences. Students will receive career guidance, including advice about graduate school application process. 1